INTEGRATIVE GENETIC APPROACHES TO GENE-AIR POLLUTION INTERACTIONS IN ASTHMA

DESCRIPTION (provided by applicant): While progress has been made in identifying the genes and exposures related to lung function and asthma, the common susceptibility factors and critical pathways underlying these pathological processes are not well understood. For example, traffic-related pollutants have adverse effects on airway hyperreactivity (AHR), lung development, and asthma, and both genome-wide association study (GWAS) and candidate gene approaches have identified genetic variants associated with asthma-related phenotypes. However, there has been limited success in identifying genes that modulate susceptibility to environmental exposures. We propose to use an innovative genetics approach in mice and humans to identify novel variants that interact with traffic-related pollutant exposures to affect lung function phenotypes and the risk of childhood asthma. In Specific Aim 1, we will characterize ~150 inbred and recombinant inbred mouse strains from the Hybrid Mouse Diversity Panel (HMDP) to determine their response to diesel exhaust particles (DEP) exposure, a model traffic-related pollutant. Lung function and AHR will be assessed using state-of-the-art plethysmography. In preliminary studies, we observe substantial variability among 8 HMDP strains characterized by this protocol, which is most likely attributable to naturally occurring genetic differences amongst these strains. In Specific Aim 2, we will use the phenotype data from the HMDP and publicly available genotypes of ~130,000 single nucleotide polymorphisms to carry out a gene-environment (GxE) GWAS and identify loci exhibiting evidence for an interaction with DEP on lung function. Positional exposure-responsive candidate genes and regions of interest will be prioritized for further evaluation using functional and bioinformatics experiments. Specific Aim 3 will build on the mouse studies and use synteny mapping to identify loci that exhibit GxE interactions to affect asthma-related phenotypes in humans. In preliminary studies, we have carried out a GWAS and a GxE GWAS for traffic exposure and asthma in ~4000 subjects from the Children's Health Study (CHS). Leveraging these results and newly developed and innovative spatial temporal exposure models, we will use a two-stage design, with replication in an independent sample, to investigate whether loci of interest identified in th CHS GxE GWAS are supported by the results of the HMDP GxE GWAS and vice versa. In Specific Aim 4, we will confirm the GxE interactions through in vivo studies. For each of two validated susceptibility loci in humans, we will use genotype data to recall 120 CHS subjects not part of the GWAS discovery sample who live in high (n=30) and low (n=30) areas of traffic-related pollution exposure levels and who are homozygous for the non- effect allele (n=30) and who carry at least one effect allele (n=30). These subjects will be phenotyped for AHR and lung function using standard spirometry protocols and assessed for clinical asthma status. The results of this integrative genomics approach in mice and humans will lead to a better understanding of how genes and environmental exposures interact to affect lung function phenotypes, which could have important clinical, epidemiological, and translational implications for the treatment of asthma.

Public health relevance
The overall goals of this project are to understand the relationship between asthma, genetic factors, and traffic- related pollution using a combination of mouse models and human populations. The results of these integrative genetics studies will lead to a better understanding of how genes and environmental exposures interact to affect lung function and asthma susceptibility, which could have important clinical, epidemiological, and translational implications for the development of novel treatment strategies.